Training clinical providers in evidence-based hypnosis for cancer pain management

Rationale: In 2019, over 1.7 million Americans will be diagnosed with cancer. Among the innumerable rigors
associated with the diagnosis, perhaps the greatest source of suffering is pain. Pain can be associated with the
cancer itself, as well as with cancer treatments including. It is estimated that 39% of patients experience pain
following curative treatment, 55% during anticancer treatment, 40%of survivors experience pain,and 66% of
patients in advanced, metastatic, or terminal disease phases report pain. Unfortunately, approximately
third
are
one-
of patients with cancer-related pain are undertreated for that pain, and that the odds of undertreatment
twice as high for minorities Major cancer organizations have published pain management guidelines which.
recognize (e.g.,
hypnosis. The inclusion of hypnosis in these guidelines is based on a evidence
supporting the clinical efficacy of hypnosis for acute and chronic pain management. Meta-analysis has
the importance of integrating mind-body approaches ASCO, NCCN), among
long history of empirical
which is
indicated that on average 77%-95% of patients benefit from hypnotic pain management relative to control
participants. However, hypnosis training is not a standard component of either standard cancer provider
education or pain management training. As a result, this clinically efficacious intervention is rarely used by
providers to help patients in need. Objective: The goal of the proposed R25E is to train cancer care providers
in hypnosis to manage cancer pain. The Specific Aims are to: 1) Refine and implement a Hypnosis for Cancer
Pain (HCaP) training program; 2) Evaluate the effectiveness of the HCaP training on providers' knowledge,
skills, attitudes, and self-efficacy for using hypnosis to manage cancer pain; and, 3) Evaluate the impact of the
HCaP training program on trainees' real-world practice, using a mixed-methods approach. The HCaP training
content is guided by sociocognitive theory. Training will focus on the following domains: 1) Understanding
Cancer Pain; 2) Understanding Hypnosis; 3) Using Hypnosis for Cancer Pain Management; 4) Using Hypnosis
for Managing Symptoms, Thoughts, and Behaviors Associated with Pain; and, 5) Hypnosis Metacompetencies
(e.g., therapeutic alliance, empathy, cultural sensitivity). The evaluation plan for HCaP is guided by Miller's
pyramid of clinical competencies, and will focus on three levels of evaluation: Knowledge and Practical
Understanding, Skills, and Clinical Practice. Methods: Cancer care providers (N=400; including medical, allied,
and psychosocial providers) from across the country will be recruited via professional organizations, listservs,
and conferences. Trainees will participate in a blended training program including multimedia E-Learning and a
2-day live workshop, with evaluations linked to each modality. Trainees will also be evaluated at 3 months
following the workshop. Long-term goals: The proposed R25E is a critical first step toward improving quality of
care and quality of life for cancer patients in pain. Connection to NCI mission: This project is consistent with the
Healthy People 2020 goal of improving quality of life of cancer patients and survivors.

Public health relevance
In 2019, over 1.7 million Americans will be diagnosed with cancer, and among the innumerable rigors associated with the diagnosis and its treatment, perhaps the greatest source of suffering is pain. Hypnosis has been shown to be a clinically efficacious and cost-effective nonpharmacologic intervention for pain, but few cancer care providers are trained in its use. The goal of the proposed R25E is to train cancer care providers in hypnosis to manage pain across the cancer continuum, so that providers may skillfully and competently deliver hypnosis to reduce the pain burden of their patients.